Elucidating the role of cardiac myofibroblasts on matrix and vasculature remodeling

In every form of heart disease, the secretion of extracellular matrix (ECM) by activated
fibroblasts, or myofibroblasts, results in cardiac fibrosis. Fibrosis impedes compliance and
pumping function, ultimately leading to heart failure due to left ventricular dilation and loss of
mechanical function. Little is known about endothelial cell and vessel adaptations to the
environment or how local mechanics and chemistry impact vessel structure and flow in vivo.
Combinatorial fibroblast and ECM mechanical and chemical crosstalk with endothelial cells are
unknown. Moreover, in vitro models aiming to assess vascular adaptations to an extracellular
environment lack physiologically relevant ECMs and instead provide exogenous ECM
components to optimize control of variables. A system for in vivo, cell-specific phenotypic
manipulation will allow for controlled perturbations at an organ level while maintaining relevant,
native ECM remodeling over time. Thus, I propose to examine transgenic mice with cardiac
fibroblast-specific overexpression of a constitutively active mitogen-activated protein kinase
kinase 6 (MKK6) to study vascular remodeling with respect to the fibroblasts and the ECM they
secrete. These mice were previously shown to develop interstitial and perivascular fibrosis after
16-20 weeks of the MKK6 gene activation without an injury stimulus, serving as an effective
model of the interstitial fibrosis preserved across the results of aging, hypertension, aortic
stenosis, and other diseases of the heart. Importantly, the remodeling seen in these diseases
does not involve a massive loss of cardiomyocytes, as in a myocardial infarction, but rather a
conserved fibroblast phenotypic change, an altered extracellular space, and/or restricted
vascular flow over time. Similarly, manipulation of the MKK6 pathway allows for overexpression
or knockdown of cardiac fibroblast activation, corresponding to increased ECM or the inability to
secrete ECM as a response to a stimulus, respectively. First, I propose to study the
biochemical, structural, and mechanical properties of the ECM as well as the macro- and
microvascular responses to activated, quiescent, and control cardiac fibroblast phenotypes in
vivo. Second, three-dimensional vessel-like structures with controlled fibroblasts and ECMs will
be engineered as in vitro platforms to define the molecular regulators of vascular remodeling
induced by microenvironmental cues. The effects of combined signaling will be resolved by
global characterization along with a reductionist method. The goal of this work is to inform heart
therapies by providing targets for steering cardiac vascular remodeling.

Public health relevance
Myocardial fibrosis is a significant contributor to every form of heart disease, the leading cause of death world-wide, and the increase in interstitial and perivascular fibrosis characteristic of aging or pressure overload in the heart has been studied in the context of left ventricular wall changes, cardiac function, and cardiomyocyte hypertrophy and apoptosis over time. However, little is known about microvascular adaptations to myocardial fibrosis or the cross-talk between the vasculature, fibroblasts, and the extracellular matrix. This work seeks to combine in vivo and in vitro models for manipulating fibroblast phenotype and fibrotic remodeling to (1) study the impact of the extracellular environment on macro and microvascular function, and (2) understand the mechanisms of fibroblast-endothelial cell-extracellular matrix crosstalk by isolating fibroblast and matrix mechanics from their chemical signals in both standard and newly proposed vessel functional models.